Identification of CYP5122A1 inhibitors as chemical probes for Leishmania biology

Summary
Human leishmaniasis is a devastating infectious disease caused by protozoan parasites belonging to
the genus of Leishmania. The disease is found in more than 90 countries and responsible for an estimated 1-2
million new infections each year worldwide. Leishmaniasis is also common in returning U.S. military personnel
from Iraq and Afghanistan, with more than two thousand cases reported since 2001. Leishmania parasites
cause disfiguring skin sores (cutaneous leishmaniasis or CL) and life-threatening infection of vital internal
organs (visceral leishmaniasis or VL). VL (~20% of all leishmaniasis cases) is the most dangerous and fatal
form of the disease, with a mortality rate close to 100% if left untreated. It is the second most deadly parasitic
disease in the world (after malaria). Despite being a serious public health problem in many endemic regions,
there are no vaccines or preventative chemotherapies available for leishmaniasis control. Current
antileishmanial drugs have limited efficacy, serious side effects and high cost. Hence, there is a major unmet
medical need for safe and effective drugs against leishmaniasis. Leishmanial CYP5122A1 is a novel
cytochrome P450 (CYP) enzyme that is essential for the survival of L. donovani, a major causative agent for
VL. Independent and our own studies have led us to hypothesize that identification of selective CYP5122A1
inhibitors as chemical probes will allow elucidation of its important role in the ergosterol biosynthesis by
Leishmania. To test our hypothesis, three specific aims are proposed to answer three main questions: 1) How
do the biochemical roles of CYP5122A1 and CYP51 compare in the ergosterol biosynthesis pathway of
Leishmania? 2) Can selective CYP5122A1 inhibitors be identified and validated? and 3) Are arylimidamides
(AIAs) and/or AIA-azole hybrids potential chemical probes to help delineate biochemical roles of CYP5122A1
in Leishmania biology? Innovative experimental approaches will be employed in the proposed project, e.g., a
new HPLC-MS/MS-based sterol assay, fluorescence-based CYP5122A1 and CYP51 inhibition assays, and
cutting-edge high content imaging-based intracellular antileishmanial assays. If successful, our proposed
project to identify novel CYP5122A1 inhibitors will elucidate this protein’s role in Leishmania biology and
validate CYP5122A1 as a drug target. Such an outcome could have a major positive impact on long-term
leishmaniasis control around the globe.

Public health relevance
Project Narrative Human leishmaniasis is a devastating infectious disease and lacks safe and effective treatments. CYP5122A1 is an essential protein to the survival of the disease-causing Leishmania parasites and hence a promising drug target. We aim to develop high throughput screening assays to identify selective CYP5122A1 inhibitors and better understand the biochemical role of this protein in Leishmania biology, which can be leveraged for future drug discovery against the disease.